Towards a Simulation of Cancer Genomes for Benchmarking Structural Variant Algorithms

Alterations to genomes either drive or mark the processes underlying the pathogenesis of cancer. One such alteration, rearrangements, heavily impact the structure of cancer genomes. By the drastic nature of these mutations on cancer genomes, we expect these to be major drivers or signatures of mutational processes. Thanks to next-generation sequencing and computational/algorithmic advances, the field of cancer research has made leaps in understanding dynamics of tumor evolution, mutational signatures, and both genetic and epigenetic drivers of different cancer types. This information has even entered the clinical realm of precision medicine to effectively treat cancer cases. However, most of this progress has relied on identifying smaller variants such as single nucleotide variants (SNVs) or small insertions/deletions (indels), largely because, paradoxically, structural variants remain difficult to detect and characterize using current sequencing technology. With the availability of widely available sequenced primary tumor tissues from various cancer consortia, the use of algorithms to reliably identify and characterize structural variants, is not only a preference, but a necessity. Although many structural variant calling algorithms exist and are in development, most have not been benchmarked uniformly or even reliably. This poses a major problem in that rearrangements clearly have major effects and should bear strong mutational signatures, but are not precisely understood because of the lack of well-developed computational tools to characterize them. No gold standard dataset of structural variants exist for any cancer type, requiring an accurate simulation to properly benchmark and develop these algorithms. This proposal will fill this gap by creating an accurate and coherent simulation of structural variants in addition to small variants to benchmark the most current set of structural variant tools for detection, as well as characterization of tumor evolution.

Public health relevance
Thoroughly characterizing large scale genomic rearrangements, which are frequent, but under-examined, in cancers and their underlying biological mechanisms hinges on the use of computational algorithms with the ever expanding resources of large genomic data available to researchers. Benchmarking these algorithms serves as a crucial first step to confidently use computational tools to detect structural variants and further describe their biological significance. Rigorous benchmarks will lead to improved algorithms that will have major implications for understanding how structural variants impact oncogenesis, cancer evolution, and even patient outcomes.